Retinal Circuitry

EY028927 Retinal Circuitry Project Summary Abstract
This grant is constructed around 3 simple conceptual questions, with 3 speciﬁc aims generated around
studying retinal circuity and how that circuitry changes in disease.
The last grant period responded to a strategic goal of the NEI, and funded infrastructure and the creation of a
set of connectomes to explore retinal wiring and serve as a resource for future work in pathoconnectomes for
those model systems from early retinal degeneration to late retinal degeneration. Connectomes that derived
from that work are a mouse retinal connectome RC2, and a non-human primate retinal connectome RC3, that
are the largest, and highest resolution retinal connectomes now on Earth, encompassing all of the resolution
required to resolve synapses, gap junctions, adherens junctions and more.
Speciﬁc Aim 1 will explore the comparative anatomy of retinal circuit topologies from mouse, to rabbit, to
non-human primate, focusing initially upon well understood retinal circuit topologies that we have worked out
in rabbit such as the Aii amacrine cell, but expanding to other retinal cell classes and network topologies
including directional selectivity.
Speciﬁc Aim 2 proposes to build 3 new pathoconnectomes from non-human primate models of retinal
disease including AMD, optic nerve atrophy, and achromatopsia, and initiate annotation in those databases,
continuing the successful work initiated in the last award period with the hypothesis that the ultrastructure of
neuronal circuit topology in degenerative disease points to stereotyped connections that reveal targets for
therapies not just in mice and rabbits, but also in non-human primate models relevant to human disease.
Speciﬁc Aim 3 will map proteins from the progressive stages of retinal degeneration in rabbit models of retinal
degeneration, and virtually map them into ultrastructural space of our existing connectomes and
pathoconnectomes. These changes in proteins reﬂect alterations in the pharmacology, morphology,
metabolism, and functional circuitry that suggest additional targets for therapeutic intervention, revealed by
speciﬁc protein expression and localizations, informative as to mechanisms associated with retinal
degeneration and remodeling. Proteins serve as mediators of cell/cell communication and contact and their
inclusion in retinal connectomes will facilitate the fundamentals of modeling.

Public health relevance
EY028927 Retinal Circuitry Project narrative This ambitious, but straightforward project is based upon the assembly, comparison, annotation and analysis of retinas from models critical to the understanding of the retinal circuits involved in vision and how they fail or are altered in retinal disease. The goals of this grant cycle are responsive to stated NEI strategic aims, and continue the annotation work of the connectomes and pathoconnectomes generated from previous work in the lab, build upon these connectomes by exploring protein expression and distributions within retinal degenerations, including late stage proteinopathies associated with pathoconnectomes and adding new non- human primate pathoconnectomes of disease models.